Immune profiling of antibodies and B cells that recognize HIV and substances in people who use substances and live with HIV (PWUSH)

SUMMARY
In response to NIDA PAS-21-270 AIDS-Science Track Award for Research Transition (R03 Clinical Trial
Optional), we propose to investigate how drug abuse may impact antibody response in HIV infection. We have
previously shown that chronic Cocaine use increased HIV-associated anti-CD4 autoantibody levels in people
with HIV (PWH) on antiretroviral therapy (ART). Through two ongoing study cohorts that collect blood specimens
from people who use substance (PWUS) and live with HIV (PWUSH) at the Medical University of South Carolina
(MUSC) and Boston Medical Center (BMC), we will have access to de-identified plasma specimens of more than
100 PWH and 100 PWUS, most of them being PWUSH. These study subjects included men and women, as well
as more than 50% racial and ethnic minorities reflecting the demographics of the studied populations seen at
the MUSC and BMC hospitals. We propose to systematically immune profile their antibody responses to HIV
Tat, Nef, and Vpr, which have been documented to contribute to neurotoxicity, neuroinflammation, and HIV-
associated neurocognitive disorders (HAND). As substance abuse alone, including the use of Cocaine and
Opioids, can cause neurocognitive impairment, and drug abuse has been associated with poor ART adherence
and exacerbates HIV disease, we will also immune profile the antibody responses to abused drugs. We propose
to analyze the specimens to test the hypothesis that drug abuse alters antibody response in HIV infection, and
rare human antibodies are developed in PWH, PWUS, or PWUSH that recognize HIV Tat, Nef, Vpr, or Cocaine
and abused Opioids with high affinity and specificity. Aim 1 (Years 1-2) will apply established ELISA to profile
plasma antibody binding titers directed to HIV Tat, Nef, and Vpr (subaim 1a) as well as to Cocaine and abused
Opioids including Heroin and Fentanyl (subaim 1b). The goals of Aim 1 include: 1) compare antibody titers to
the measured HIV antigens between PWH with and without substance use; 2) compare antibody titers to the
measured substances between PWUS with and without HIV; 3) identify the top 5% subjects who mounted the
highest antibody titers for antigen-specific B cell sorting by FACS in Aim 2 (Year 2). Based on the Aim 1 plasma
binding data, up to N = 6 PBMCs will be selected for FACS in Aim 2 to assess the frequency of memory B cells
that stain positively for the tested antigens – a step critical to reliably sort antigen-specific B cells for B cell
receptor (BCR) sequencing and human monoclonal antibody (mAb) discovery. It would be exciting to
immediately identify human mAbs that display the desired specificities; however, such mAb discovery and
characterization would likely take a major effort and thus go beyond the scope of the R03. The data and findings
from this proposal, however, would likely lead to future R01 applications focusing on the development of
antibody-based interventions to specifically improve on meeting the prophylactic and therapeutic needs of the
vulnerable PWUSH populations.

Public health relevance
NARRATIVE In two study cohorts of people who use substance (PWUS) and live with HIV (PWUSH), we propose to systematically profile their plasma antibodies that target HIV Tat, Nef, and Vpr, as well as substances including Cocaine and Opioids. Based on the plasma antibody profiling data, we aim to select a subset of PWUSH to further profile their peripheral blood memory B cells that recognize the relevant HIV antigens and substances with high affinity and specificity. Findings from this study will enable the discovery of human monoclonal antibodies and development of antibody-based interventions to improve on meeting the prophylactic and therapeutic needs of the vulnerable PWUSH populations.